Deciphering multi-scale differentiation and patterning cues driving whole craniofacial joint regeneration

PROJECT SUMMARY
Joint injuries and diseases are the leading causes of disability worldwide. Synovial joints are composed of
complex and structurally integrated tissues, including specialized lubricating articular cartilage and connective
tissues like ligaments that stabilize joint movement. In mammals, joint tissues have a poor healing capacity. Even
after reconstructive surgery, ligaments fail to reestablish the biomechanical properties of uninjured joints, leaving
patients at high risk for re-injury or degenerative joint disease. This limited healing capacity results from a failure
of differentiation involving the development of scar tissue in place of mature ligamentocyte and chondrocyte
lineages. Currently, we have a limited understanding of the underlying molecular cues that drive lineage
specification of the most functionally critical joint cell types, particularly articular cartilage and ligaments. In order
to devise improved strategies for regenerative medicine therapeutics for joint tissues, this project will leverage a
unique whole joint regeneration model in the highly regenerative zebrafish. While joint injuries fail to heal in
mammalian models, we find that endogenous skeletal progenitor cells robustly regenerate synovial joint tissues
after a catastrophic injury in zebrafish. The new joint integrates with surrounding tissues to restore biomechanical
function. Critically, this high regenerative capacity includes the differentiation of new lubricating articular cartilage
and fully integrated new joint-supporting ligaments. Here, through combined genetic and spatial analyses, we
will identify and functionally dissect the underlying molecular regulation of progenitors and characterize their
physical interactions with their respective regenerative niches required to regenerate complex 3D joint tissues.
This high-risk/high-reward proposal will have wide-ranging impacts on our understanding of joint regeneration
via repair from endogenous cell sources and inform improved tissue engineering approaches to whole joint
replacement in joint disease.

Public health relevance
PROJECT NARRATIVE The Smeeton lab aims to decipher the language of regeneration and decode the signals required to repair a complex anatomical structure. We will probe a unique whole joint resection model with the experimental advantages of the zebrafish system, including the rapid development of new genetics tools to live image, lineage trace, and manipulate progenitor cells during regeneration. By combining these powerful in vivo tools with our in silico expertise in single cell sequencing and cutting-edge spatial transcriptomics techniques, we will tease apart the molecular control of adult synovial joint regeneration.